Immune selection of HIV-1 reservoir cells in human clinical trials

Abstract
HIV-1 reservoir cells are a small subset of CD4 T cells that harbor chromosomally integrated HIV-1 DNA, persist
life-long and represent the major barrier to a cure of HIV-1 infection. For a long time, proviruses in these cells
have been regarded as transcriptionally silent, which permits them to escape from host immune recognition and
to resist antiviral host immunity. However, recent studies enabled by single-genome and single-cell analytic
technologies have shown that these cells can frequently be transcriptionally active and vulnerable to host
immune responses. In line with this observation, our recent work suggested that viral reservoir cells may be
subject to immune-mediated host selection forces that promote the elimination of proviruses integrated in
permissive chromatin locations supporting active viral transcription, while proviruses in repressive
heterochromatin locations appear to have a selection advantage. The central hypothesis of this application is
that these naturally occurring immune selection mechanisms can be accelerated through specific immunological
interventions that exploit weaknesses and vulnerabilities of HIV-1 reservoir cells. To address this, we propose to
apply a panel of novel single-genome/single-cell analytic techniques to analyze HIV-1 reservoir cell evolution in
three recently-conducted clinical trials in which different interventional strategies were tested in ART-treated
persons. By leveraging existing samples from human interventional studies for such high-resolution analytic
approaches, we will be able to identify specific immunological pathways that may be able to effectively target
viral reservoir cells, and detect specific susceptibilities and vulnerabilities of the HIV-1 reservoir cell pool that can
be exploited in future, more targeted interventions. In specific aim 1, we will use novel single-cell phenotypic
profiling technologies to analyze the interplay between viral reservoir cells and autologous innate and adaptive
immune effector cells in the ACTIVATE study, a randomized-controlled study focusing on the combined
administration of Panobinostat (a potent histone deacetylase inhibitor) with pegylated IFN-α2a. In specific aim
2, we will perform single-cell chromosomal integration site monitoring and phenotyping profiling assays to study
HIV-1 reservoir cell evolution in the RIVER study, a randomized-controlled study in which a therapeutic T-cell
vaccine was administered in conjunction with vorinostat to individuals with acute HIV-1 infection. In specific aim
3, we will investigate immune selection pressure against HIV-1 reservoir cells in the “kitchen sink study”, a human
clinical trial focusing on co-administration of a therapeutic T cell vaccine in conjunction with broadly-neutralizing
antibodies and an innate immune modulator (TLR9 agonist). Together, these detailed investigations, involving a
series of cutting-edge, single-cell next-generation sequencing approaches, will permit to identify evolutionary
selection processes in the viral reservoir cell pool in response to interventional manipulations of human antiviral
immune activity and be highly informative for efforts to limit HIV-1 long-term persistence through clinical
interventions.

Public health relevance
Narrative HIV-1-infected cells persist lifelong despite highly efficient antiretroviral therapy, but may be vulnerable to specific host immune responses. Here, we will use novel single-cell next-generation sequencing approaches for profiling footprints of immune selection in three distinct human clinical trials testing specific immunological interventions.